Core E Data Management Core

CORE E PROJECT SUMMARY
Recent advances in high-throughput immune phenotyping and genomic technologies have enabled profiling of
host immune responses to vaccination and infection at unprecedented detail, at both the tissue and cellular
level. The goal of the VIVA DATA MANAGEMENT AND ANALYSIS CORE (DMAC, CORE E) will be to
provide comprehensive data management and computational analysis capabilities for the gene expression,
antibody, cytokine and chemokine profiles generated for PBMCs and plasma from vaccinated and infected
individuals, as well as from human tonsillar histocultures (HC) treated with different vaccines against Severe
Acute Respiratory Syndrome coronavirus 2 (SARS-CoV-2; Project 1), influenza virus (IV; Project 2) or
Dengue virus (DENV; Project 3). In Aim 1, this core will perform computational analysis of high-throughput
tissue-level transcriptional, antibody, cytokine and chemokine profiles generated for all individuals and
histocultures in each project by the IMMUNE PHENOTYPING CORE (CORE C) and the GENOMICS CORE
(CORE D). In Aim 2, we will use the results from the analyses of bulk PBMC and plasma profiles – in close
coordination with each project team – to help inform the selection of samples for detailed profiling at the
cellular level using the latest single-cell CITEseq and spatial transcriptomics technologies by the GENOMICS
CORE. We will also be responsible for analyzing the resulting single-cell datasets using well-established
pipelines to show how changes in cell composition and expression at the cellular level drive changes at the
tissue level. In Aim 3 we will further combine data at the tissue and cellular level across all three projects for an
integrated analysis of host responses to vaccination against each pathogen to identify common and vaccine-
specific components of these responses. This integration will be facilitated by the centralized cross-project data
management facilities provided by this core, as well as coordinated data generation by the IMMUNE
PHENOTYPING CORE and GENOMICS CORE that use the same platforms and technologies to profile
samples across all projects. Finally, we will interface with ImmPort, directly or through the HIPC Coordinating
Center, to ensure that all data, analysis results, and analysis code is made publically available in a timely
manner. Altogether we expect that our multi-scale computational approaches will enable a comprehensive
characterization of the relationship between vaccination, host immune responses and vaccine outcomes.